Emerging antibiotic resistance in Gram-negative pathogens

PROJECT SUMMARY
Burkholderia multivorans is a successful pathogen and a member of the B. cepacia complex (Bcc) that
causes pneumonia in immunocompromised individuals with underlying lung diseases, such as cystic fibrosis
(CF) and chronic granulomatous disease (CGD). Bcc consists of a group of 17 closely related Gram-negative
bacteria with extreme genetic capacity and metabolic diversity. Several Bcc members can trigger chronic airway
infections in CF patients and have emerged as opportunistic pulmonary pathogens. B. multivorans and B.
cenocepacia are the two most commonly isolated species, which are threats for outbreaks. Bcc infections in CF
patients are associated with enhanced morbidity and mortality. They also have the capacity to cause rapid clinical
deterioration with septicemia that leads to death. Several outbreaks of B. multivorans causing severe morbidity
and mortality in both CF and non-CF patients have occurred.
Bcc pathogens are intrinsically resistant to a broad range of antimicrobials, including b-lactams,
fluoroquinolones, aminoglycosides, polymyxins and cationic peptides, creating a major challenge to the
treatment of Bcc pulmonary infections. Hopanoids play a predominant role in supporting outer membrane stability
and barrier function in B. multivorans, thus participating in the resistance to polymyxin B and colistin. Hopanoids
are pentacyclic triterpenoid lipids that are capable of inserting in bacterial membranes and contributing to their
stability and stiffness. Hopanoids help membranes withstand damaging stress conditions, including high
temperature, low pH and the presence of antibiotics. Importantly, hopanoid production plays an important role in
the physiology and pathogenesis of B. cenocepacia.
In spite of the importance of hopanoids in bacteria, the mechanism of intracellular hopanoid trafficking has
not been explored. We propose to target the B. multivorans HpnN (hopanoid biosynthesis-associated resistance-
nodulation-cell division (RND)) transporter, which is essential for cell wall remodeling in this Gram-negative
bacterium. Our working hypothesis is that HpnN plays a major role in the intrinsic antimicrobial resistance of B.
multivorans by shuttling hopanoids from the cytoplasmic membrane to outer membrane, strengthening the cell
wall. The process of intracellular hopanoid trafficking may also require the participation of the periplasmic
lipophilic protein HpnM. We will elucidate the molecular mechanisms of multidrug resistance in B. multivorans
mediated by HpnN and HpnM.
We will define crystal structures of B. multivorans HpnN both in the absence and presence of hopanoids.
Based on the structural information, we will identify important residues for hopanoid recognition and transport.
Our preliminary data strongly suggest that HpnN shuttles hopanoid molecules from the outer leaflet of the inner
membrane to the outer membrane. Simulations have shown the exact pathway through HpnN for diploptene,
indicating how this hopanoid molecule is exported through the channel formed by the HpnN transporter. We will
ascertain the role of HpnM in hopanoid trafficking. We will also apply phage display methodology to identify novel
peptides that strongly interact with HpnN or HpnM, inhibiting their function to transport hopanoids. We
hypothesize that we will be able to produce unique inhibitors that render B. multivorans susceptible to antibiotics.
Peptides that inhibit the function of HpnN will be used to co-crystallize with this transporter. The structures will
allow us to understand the mechanism of inhibition. In addition, Galleria mellonella and mouse models of infection
will be used to test the efficacy of these peptide-based inhibitors. These peptides would not inhibit the growth of
Burkholderia cells in the absence of antibiotics. However, they can render bacteria susceptible to antibiotics and
act as “antibiotic adjuvants” for the treatment of infections. If successful, our strategy could be transferred to
other bacterial pathogens, which would provide an added mechanism to treat infections.

Public health relevance
PROJECT NARRATIVE Burkholderia multivorans is one of the two most commonly isolates of the B. cepacia complex (Bcc), which causes pneumonia in immunocompromised individuals. The hopanoid biosynthesis-associated resistance- nodulation-cell division (HpnN) transporter exports hopanoid lipids to the B. multivorans outer membrane, conferring resistance to a variety of antibiotics. This proposal will define the structure and function of the HpnN transporter, elucidate the role of the HpnM periplasmic lipoprotein, and identify novel peptides that inhibit the function of the HpnN and HpnM proteins. In addition, a Galleria mellonella infection followed by a murine neutropenenic thigh infection model will be employed to test strategies for treating infections.